Administrative Core

Responsive and intelligent management and administration are fundamental to the success of any Center grant. Such supervision is particularly important for the Roybal Centers insofar as they are meant to be translational centers that strengthen diverse linkages: between basic and applied research, between public and private sectors, between conventional and innovative ideas and between established and new investigators. Because large-scale independently funded research studies are not part of the Roybal centers program, a Center can only be considered successful in the context of how well it is able to leverage its organization and modest resources to a larger productive whole.